Touch to learn: How sensory cues impact word segmentation and learning

Project summary
Infants experience language in a rich multimodal world in which sounds, sights, smells, tastes, and touches
occur together. How do these modalities, and their presence in the input, contribute to fundamental aspects
of lexical acquisition? We explore how infants exploit multi- compared with uni-modal input as they segment
wordforms from continuous speech and map meanings to wordforms. We hypothesize that the ability to make use
of multimodal information including touch (a fundamental social signal) in the input facilitates infants' language
learning by contributing information relevant to the alignment of word boundaries and the association of word
meaning to wordforms. In Aim 1 (Experiments 1a-c) we determine whether sensory input that incorporates
more modalities aligned with speech input, results in improved segmentation of the speech stream and improved
attention to word edges for infant learners. In Aim 2 (Experiments 2a and 2b) we determine whether sensory
input that incorporates more modalities associated with objects results in improved word learning for language
learners. Our approach builds on our preliminary work showing that (a) caregiver touch+speech alignment and co-
occurrence is common in interactions with infants and (b) infants use multisensory information in early language
learning tasks. The design exploits behavioral and physiological measures to examine whether the alignment
(Aim 1) and/or association (Aim 2) of multimodal touch, speech, and visual cues inﬂuence language learning in
typically developing children.
The proposed research is signiﬁcant for its clinical and theoretical implications. First, it is clinically signiﬁcant
since exploring the role of multimodal cues on language learning may impact clinical approaches since current
language therapies or interventions concerning the input tend to emphasize auditory alone or auditory+visual
domains, but not tactile ones. Thus, discoveries concerning the child's use of multimodal information which
includes touch in language learning could lead to new avenues for early intervention for infants and toddlers
showing delayed language acquisition or who are at-risk of language disorders. Second, this work is theoretically
signiﬁcant since it explores how multimodal information may help the learner at different levels of representation
(wordform representations, semantic representations) in ways that could constrain the language learning problem.
The ﬁndings from this research will challenge our views concerning what kinds of informational streams infants
attend to when learning language, and thus inﬂuence intervention and parenting practices.

Public health relevance
Project narrative Given the complexity and multimodal nature of the input to the child, learning language should be a challenging task, but most young infants proceed in achieving language competence with enormous speed. We hypothesize that the alignment and use of multimodal cues, including touch, in the input may play a key role in this achievement and explore this hypothesis in a series of experiments. The primary translational signiﬁcance of this work is the potential to provide insights into language learning mechanisms, which ultimately could impact treatment protocols and interventions or parent-training programs with high-risk infants consistent with the mission of NIH.